GLUCOSE METABOLISM IN PREGNANCY--EFFECT OF GESTATIONAL DIABETES

To quantitatively examine the partitioning of glucose utilization into oxidation, recycling, and other synthetic processes in normal pregnant women and the effect of gestational diabetes on these parameters; examine the effects of therapeutic interventions on components of glucose utilization in gestational diabetics; examine the effects of augmentation of glucose supply parenterally in normal and gestationally diabetic subjects.